Matrix regenerative nanotherapeutics for small abdominal aortic aneurysm repair

Abstract Our objective is to investigate a new, minimally-invasive regenerative nanotherapy to arrest or regress growth of small (<5.5 cm diameter) abdominal aortic aneurysms (AAAs). AAAs are localized expansions of the abdominal aorta that ultimately rupture. Early surgery on small AAAs provides no treatment benefit and no other proven therapies exist. While reinstating homeostasis of the structural extracellular matrix (ECM; collagen and elastic fibers) in the AAA wall is critical to stop or reverse AAA growth, this is impeded by a) their chronic breakdown in the aorta wall by upregulated matrix metalloprotease (MMPs) enzymes and b) lack of approaches to overcome intrinsically deficient and defective elastic fiber regenerative repair by adult vascular smooth muscle cells (SMCs). Oral dosing of doxycycline (DOX) has been shown to inhibit MMPs in the AAA wall to slow AAA growth, but has systemic side effects and inhibits elastin biosynthesis at the high doses. To avoid this, we have formulated biodegradable polylactic-co- glycolic acid (PLGA) nanoparticles (NPs) for steady, sustained release of doxycycline (DOX), an MMP inhibitor within the AAA wall following one-time, catheter-wise infusion to a transiently flow-occluded AAA segment. At the much lower release levels (<10 μg/ml), DOX was found to maintain its MMP inhibitory effects, but also to beneficially stimulate elastic matrix neoassembly (elastogenesis). We also uniquely surface-functionalized our NPs with cationic amphiphiles that have pro-elastogenic & anti-proteolytic separate from the effects of the released DOX. Building on this promising preliminary data, we now propose to confirm the signaling mechanisms underlying the unique pro- matrix regenerative and anti-MMP effects of DOX at sub-oral doses, identify DOX-NP formulations that provide a significant stimulus to biomimetic and stable elastic fiber assembly, design and test a magnetic guidance system for efficient NP delivery to the AAA wall, and demonstrate efficacy of the DOX-NPs in regressing already formed small AAAs in a preclinical (rat) model. Our aims will test hypotheses that 1) pro-elastogenic effects of DOX are mediated by JNK decreases which trigger increases in TGF-β1, 2) quantity and quality of elastic fiber assembly can be regulated by modulating severity of JNK inhibition by DOX, 3) DOX is more effective than SP600125 (at their IC50 doses for JNK) in stimulating elastin since it also directly inactivates MMPs, and 4) regenerative stimuli due to DOX-NPs will restore matrix homeostasis in the AAA wall to arrest its growth. Aim 1 will correlate severity of DOX inhibition of JNK to downstream elastogenesis and anti-MMP outcomes in rat AAA SMC cultures. Aim 2 will generate DOX-NP formulations with superior pro-elastogenic & matrix reparative properties. Aim 3 will develop a magnetic system to target DOX-NPs to the AAA wall in a rat model. Aim 4 will assess therapeutic efficacy of magnetically-responsive DOX-NPs in rat AAAs. If successful, our approach will be validated in larger animal models to rationalize future clinical trials. Our approach can prospectively reduce or delay need for future surgery in high risk elderly AAA patients.

Public health relevance
Project Narrative Abdominal aortic aneurysms (AAAs) are potentially fatal conditions of the aorta, which involve slow growth in size of the vessel, and loss of wall flexibility leading to rupture. Surgery on small, diagnosed AAAs is risky and provides no benefit; no other established non-surgical treatments are available to stop or reverse small AAA growth. Recent studies have shown that oral dosing of a drug, doxycycline (DOX), inhibits enzymes that breakdown the structural components of the aortic wall thus slowing vessel expansion. However, this mode of delivery causes several body-wide side effects and inhibits the already poor potential of cells in the diseased aorta wall to replace disrupted elastic fibers, the structures that allow the vessel to stretch and recoil. In this study, we are investigating a minimally invasive approach to reverse small AAA growth that involves use of small, nano-sized biodegradable polymer particles for sustained and local delivery of DOX within the AAA wall tissue. The DOX release from these particles will be a small fraction of the oral dose, and one at which the drug will both prevents elastic fiber breakdown and also simultaneously stimulate new fiber formation by diseased vascular cells. Our particles are also designed such as to add on to these effects due to the released drug. This treatment approach can potentially restore healthy vessel structure in high risk older patients diagnosed with small AAAs, without need for surgically intervene.